Cellular crosstalk regulating cholangiocyte proliferation following extrahepatic bile duct injury

Cholangiopathies are incurable biliary tree disorders characterized by tissue injury with neutrophil recruitment,
cholangiocyte hyperproliferation, and stromal cell expansion. Signals driving extrahepatic bile duct (EHBD)
inflammation and proliferation are poorly understood. This application aims to answer fundamental questions
about injury-driven processes promoting biliary proliferation. The rationale for these studies is that understanding
molecular mechanisms of EHBD inflammatory and proliferative responses can inform therapeutic strategies to
prevent and treat complications of cholangiopathies. My preliminary data shows a massive increase in
cholangiocyte proliferation within 24 hours after acute injury. Further, increased cholangiocyte Hedgehog (HH)
ligand targets stromal cell CXCL1, which recruits neutrophils to the injured tissue. My project focuses on
uncovering the mechanisms of this complex crosstalk involving epithelial cholangiocyte – stromal fibroblast –
neutrophil signaling to promote biliary proliferation and facilitate tissue repair. Biliary hyperproliferation is
associated with HH-dependent expression of FOSL1, a transcription factor known to mediate proliferative
responses in other tissues. IL1β is increased post EHBD injury in neutrophils and can regulate FOSL1. The
overarching hypothesis for this proposal is that in response to EHBD injury, cholangiocytes secrete Indian
HH which induces GLI1+ fibroblasts to produce CXCL1, leading to neutrophil recruitment and promotion
of cholangiocyte proliferation through a IL1β/FOSL1-dependent mechanism. I will use state-of-the art in
vivo genetic mouse and pharmacologic approaches combined with ex vivo human and mouse organoid and
primary culture models to define the molecular mechanisms of cellular crosstalk regulating EHBD repair. Bile
duct ligation (BDL) will be used as an acute biliary injury model. CUT&RUN chromatin mapping, cell isolation by
flow cytometry, and RNA-seq approaches will be conducted within this proposal. Findings will be validated using
archived biliary tissues from patients with/without cholangiopathy. Aim 1 will focus on GLI1+ stromal cells and
regulation of Cxcl1 expression to determine if HH signaling induces fibroblasts to express Cxcl1 via direct
transcriptional activation by GLI1. This aim will use reporter mice to isolate GLI1+ cells for downstream in vivo
and ex vivo analyses. Pharmacological activators and inhibitors of HH signaling will be used to test effects of
GLI1 modulation on gene expression. Aim 2 will focus on neutrophil-derived pro-proliferative signals to test
whether neutrophils promote biliary proliferation via a IL1β/FOSL1-dependent mechanism and identify candidate
neutrophil-derived factors. Aim 2 will use reporter mice to isolate neutrophils for downstream in vivo and ex vivo
analyses. A genetic mouse model will test effects of Fosl1 deletion on biliary proliferation post EHBD injury. This
proposal will allow me to gain proficiency in state-of-the-art tools and generate preliminary data for a successful
R01 application. Ultimately, defining the cellular and molecular mechanisms regulating EHBD injury responses
may inform novel therapeutic strategies to improve outcomes of patients with cholangiopathies.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because cholangiopathies, which often affect extrahepatic bile ducts, are poorly understood and, therefore, have no effective treatment options. This project will unveil cellular and molecular mechanisms underlying extrahepatic bile duct responses to injury and inform potential strategies for treatment of cholangiopathies and prevention of their complications. Thus, the proposed research is relevant to the NIH mission that pertains to improvement of people’s health and quality of life.